Isocitrate dehydrogenase (IDH) mutations as drivers of organelle stress and dysfunction

ABSTRACT/SUMMARY
Human isocitrate dehydrogenase 1 and 2 (IDH1, IDH2), which are highly conserved across many species, are
responsible for the reversible NADP+-dependent oxidation of isocitrate (ICT) to α-ketoglutarate (αKG).
Mutations in IDH have been implicated in > 80% of lower grade gliomas, 40% of chondrosarcomas, and ≤ 20%
of acute myeloid leukemia cases. Though their conventional activity typically is ablated, IDH1 and IDH2
mutations confer a neomorphic activity: the NADPH-dependent production of oncometabolite D-2-
hydroxyglutarate (D2HG). D2HG inhibits αKG-dependent enzymes like DNA and histone demethylases leading
to epigenetic changes, and NADPH depletion can result in oxidative stress. The most common point mutations
found in tumors are IDH1 R132H and IDH2 R140Q and R172K, though many other amino acid substitutions
have been reported at these positions. Though much progress has been made in understanding the role of
IDH in cancer, including the development of FDA-approved inhibitors, many key fundamental questions
remain. We have recently shown that mutations in IDH1 have unique catalytic profiles, and we used a host of
structural methods to elucidate mechanisms driving these kinetic differences. This work highlighted a
surprising gap in our understanding of IDH – it is not yet clear which residues drive the chemistry of the
neomorphic reaction. Here, we seek to determine the key features of disease-driving IDH1 and IDH2 mutants,
including elucidating the interactions of wild type and mutant monomers upon dimerization to form the catalytic
dimer, and the mechanisms of substrate binding and catalysis. A comprehensive understanding of kinetic and
structural features of IDH1 and IDH2 mutants is important for elucidating the mechanistic features of
dehydrogenases, a ubiquitous enzyme class. These discoveries can also serve to guide development of next
generation inhibitors, and to help predict patient response to therapies. We also recently showed that unique
IDH1 catalytic profiles can in turn alter D2HG levels in vitro and in vivo to affect tumor aggressiveness. Here,
we return our focus to the most common mutations found in patients as we seek to determine the cellular
consequences of IDH1 mutations beyond their role in altering DNA and histone methylation. Further, as IDH1
localizes to the cytosol and peroxisomes, this raises the possibility of organelle-specific effects of IDH1
mutations, which is an area that is underexplored. Identifying new pathways affected by IDH1 mutation allows
us to better understand the roles wild type IDH1 plays to maintain healthy metabolism, as well as helps us to
identify new pathways that may be ripe for therapeutic targeting. In our quest to establish the mechanisms of
metabolic enzyme function in health and disease from the chemical to the in vivo levels by leveraging kinetic,
structural, cellular, xenograft, and -omics technologies, we can establish the unique consequences of disease-
relevant mutational variants in the most commonly mutated metabolic enzyme found in tumors.

Public health relevance
PROJECT NARRATIVE Mutations in isocitrate dehydrogenase (IDH) can lead to cancers like gliomas, acute myeloid leukemias, and chondrosarcomas, but the mechanistic consequences of these mutations are far from being fully understood. We will leverage our recent discoveries probing IDH mutations at the biochemical, structural, cellular, and in vivo scales to understand how IDH proteins interact and perform their catalysis and to identify new cellular roles of IDH activity in health and disease. We expect this work will establish foundational features of IDH activity, ultimately leading to illumination of new disease-driving pathways, tools to predict patient prognosis, and identification of structural features ripe for therapeutic targeting.